Characterization of a novel non-hallucinogenic psilocybin derivative for alcohol use disorder

Abstract
The use of psychedelic molecules in the treatment of alcohol/substance abuse and mental health disorders
is one of the most controversial topics in modern society. This skepticism is due to its historic recreational
use for hallucinogenic effects and potential for abuse. However, recent investigations specifically around
psilocybin and derivatives reveal increasing evidence for their therapeutic use in mental health,
neurocognitive, and substance abuse disorders. Safe and effective treatments for each of the
aforementioned ailments require greater attention as we progress as a society.
We have performed detailed structure-activity relationship analyses of various tryptamine analogs to
probe their biological properties and develop effective treatments with reduced hallucinogenic properties.
This proposal provides a detailed plan to further develop a more selective serotonergic-targeting, non-
hallucinogenic psilocybin derivative for alcohol use disorders with promising preliminary efficacy in
alcohol preferring mice that surpass the activity of psilocin over a 60-day dosing period.

Public health relevance
Narrative There is considerable evidence from research and literature that molecules such as psilocybin and other N, N-dimethyltryptamine (DMT) derivatives are safe and effective alternatives to psilocybin-producing mushrooms or other illicit sources; however, expensive psychotherapy-assisted treatments limit accessibility to the average patient. Non-hallucinogenic alternatives could expand accessibility and affordability while offering treatments options similar to current pharmaceutical standards of care. From a medicinal chemistry perspective, detailed structure-activity relationship studies have rarely been performed on the psilocybin (4-substituted-DMT) scaffold, especially with an additional 2-subsitution. Literature has shown for nearly 20 years that psilocybin is an effective anti-addiction treatment in both alcohol use and smoking cessation disorders. Extensive exploratory and preclinical work has already been performed over the past 4 years in order to identify an ideal non-hallucinogenic candidate. This proposal details the preclinical evidence to support continued studies of this derivative and its tailored serotonergic activity towards alcohol use disorder. This uniquely designed non-hallucinogenic psilocybin analog provides a potentially more accessible, insurance-backed alternative for patients and prescribing physicians with preliminary evidence supporting a novel mechanism of action.